ETS-family Transcription Factor Mediated Control of Pulmonary Inflammation Induced by Influenza Viruses

PROJECT SUMMARY/ABSTRACT
Influenza viruses induce significant morbidity and mortality in the human population every year. Despite the
medical importance of influenza disease, the mechanisms underlying the viral pathogenesis are incompletely
understood. After influenza viruses initiate infection, cellular pattern recognition receptors detect components of
the virus and inflammatory cytokines such as type I interferon (IFN) are produced. While an important part of
early control of viral replication and spread, excessive or prolonged IFN signaling is associated with
immunopathology and more severe viral disease. We have previously shown that some respiratory epithelial
cells can survive direct viral infection, display prolonged IFN signaling, and contribute to lung immunopathology
likely by delaying epithelial regeneration. Thus, understanding how type I IFN is downregulated represents a
critical aspect of influenza disease pathogenesis. Interestingly, however, we failed to detect a difference in any
of the canonical IFN induction or suppression pathways in the cells that survived direct viral infection. We
therefore hypothesized that there must be additional regulators of IFN signaling relevant for IFN control
during the resolution of influenza virus-induced disease. By leveraging genome wide CRISPR activation
screening approaches, we were able to identify a previously uncharacterized regulator of IFN signaling (the ETS-
family transcription factor ETV7) which upon induction, non-uniformly suppressed the expression of individual
interferon stimulated genes (ISGs). The major goal of this application is to define this novel, ETV7 mediated, IFN
regulatory mechanism and understand its physiological importance during influenza viral disease in vivo. In Aim
1, we will perform high-throughput biochemical analysis of ETV7 binding across all ISG promoters and then
define how intrinsic ETV7 affinities for primary promoter sequences affect transcription factor competition. This
work will reveal the first regulatory pathway capable of differential suppression of individual ISGs. In Aim 2, we
will focus on understanding the cell type-specific importance of ETV7 regulation during respiratory epithelial
innate immune responses and tissue regeneration after infection. These experiments will establish a new
mechanism for how the balance between the antiviral signaling and regenerative capability in the lung is
maintained. Finally, in Aim 3, we will explore how dysregulation of ETS-family transcription factors affects viral
pathogenesis and recovery from infection in vivo. Successful completion of these studies will increase our
understanding of the mechanisms that regulate IFN signaling during influenza virus infection and potentially
inform new interventions to limit the severity of viral disease.

Public health relevance
PROJECT NARRATIVE Inappropriate type I interferon (IFN) signaling is associated with excessive immunopathology during and after influenza A virus infection. We performed a genome wide over-expression screen for previously undescribed controllers of IFN signaling and identified the interferon stimulated gene ETV7 as a transcriptional suppressor of this pathway. The major goal of this application is to define the mechanisms underlying ETV7 function to enable novel intervention strategies which limit immunopathology and enhance lung regeneration after viral infection.